TUFCCC/HC Regional Comprehensive Cancer Health Disparities Partnership

PROJECT SUMMARY
Administrative Core
TUFCCC: Grace X. Ma, PhD (Contact PI) and Camille Ragin, PhD, MPH (MPI)
HC: Olorunseun Ogunwobi, MD, PhD (Contact PI) and Joel Erblich, PhD, MPH (MPI)
The Administrative Core (AC) of the TUFCCC/HC Regional Comprehensive Cancer Health Disparities
Partnership 2.0 (aka: SPEECH 2.0) builds on an established effective leadership, governance infrastructure and
foundation of productivity and impact. Over the past 5 years, the Partnership directly supported 84 investigators,
56 cancer disparities research projects, mentored 180 trainees (61% received career or education
advancements) and engaged 50 diverse community-based organization partners in cancer prevention activities.
The overall goal of the AC for SPEECH 2.0 is to further enhance cancer health disparities research infrastructure
and our administrative leadership to provide vigorous scientific/programmatic oversight and integration of
research projects, education/training, and community outreach and engagement activities to be conducted by
the Partnership, ensuring high-quality standards of excellence and impact on advancing cancer equity in
underserved Black/African American (AA), Asian Pacific Americans (APA) and Hispanic American/Latinx (HA)
communities in the Philadelphia, NJ and NYC (PNN) region. The AC’s functions include, but are not limited to,
providing leadership, oversight, fiscal management, coordination, integration, and communication to support the
Partnership’s day-to-day operations. The AC will ensure the efficient, effective, and synergistic performance of
the proposed Partnership’s aims, throughout all of the projects, cores, and shared resources. The aims of the
integrated TUFCCC/HC Administrative Core are as follows: Aim 1. Leverage the established organizational
structure to enhance operational capacity and provide robust administrative and fiscal support for overall
program activities of TUFCCC/HC Partnership cores and research projects. Aim 2. Facilitate and enhance
communication and collaboration opportunities to promote team science among Partnership faculty, trainees,
investigators, and program coordinators. Aim 3. Strengthen and maintain leadership infrastructure to ensure the
integration of cores, projects, shared resources, as well as inter-institutional initiatives across Partnership and
beyond. Aim 4. Establish and maintain sustainable infrastructure to support and ensure the competitiveness of
the Partnership's research project portfolio. Aim 5. Direct and support continuous quality improvement using
multiple metrics to inform decision-making in planning and evaluation across all cores and projects of the
Partnership. Both institution leaders have and will continue to provide exceptional commitments to SPEECH 2.0.
AC has been well established and integrated, and will continue to be jointly led by experienced multidisciplinary
cancer research leaders. The AC team demonstrated not only synergistic accomplishments during SPEECH 1.0,
but also strong long-term commitments to the shared vision of advancing cancer equity among underserved
populations. Inclusive Excellence will serve as our guiding principle across all cores and projects. In practice,
the AC core will be committed to addressing systemic barriers and incorporating diversity, equity and inclusion
efforts into all aspects of our Partnership for the proposed next U54 grant period.